TASTE QUALITY ALTERATION

Subjects participate in a range of tests to: determine genetic taste status; determine perceived intensity or oral stimulus; measure liking/disliking of oral stimulus and foods; measure food and nutrient intake; and to determine body composition. We plan to continue data collection throughout the spring, summer and fall to reach the total anticipated number of subjects.